An evaluation of Beta-nicotyrine as a potential contributor to the abuse liability of e-cigarettes

Project Summary/Abstract
Addiction to ENDS products is a newly emerging form of nicotine addiction. Understanding the product
characteristics and the harmful and potentially harmful constituents (HPHCs) that contribute to ENDS addiction
is vital for effective FDA CTP regulation. This HPHC list, however, was last updated in 2012, just prior to the rise
in ENDS popularity. Since two of the five addiction-related HPHCs are tobacco-related minor alkaloids (e.g.,
nornicotine), then it suggests research on ENDS-specific minor alkaloids is warranted. One uniquely prevalent
minor alkaloid in ENDS is β-nicotyrine, which is formed by aging and/or aerosolizing e-liquids and can reach
25% of nicotine levels when vaped. Our pilot work found that β-nicotyrine approximately doubles the half-life of
nicotine and that it functions as a nicotinic acetylcholine receptor (nAChR) agonist with functional efficacy at
α4β2 nicotinic-AChRs similar to nornicotine. Given its a) abundance in ENDS aerosols, b) similarities to
nornicotine, and c) ability to inhibit nicotine metabolism, β-nicotyrine may contribute to the addiction-relevant
effects of ENDS and represent a novel HPHC. If we find β-nicotyrine has abuse liability or increases the abuse
liability of nicotine, it suggests the CTP should consider it a HPHC given that the FDA considers other less
prevalent minor alkaloids as HPHCs. The present project will initially characterize the pharmacokinetics of β-
nicotyrine and its interaction with nicotine metabolism, and then subsequently determine its effects in FDA-
recommended animal models of abuse liability, including drug discrimination, intracranial self-stimulation (ICSS)
and drug self-administration. This project is innovative because: 1) it extends research on minor alkaloids, a
class of constituents that includes HPHCs with established abuse liability, 2) it will be the first to examine the
abuse liability of β-nicotyrine and its ability to alter the abuse liability of nicotine, including at vaping relevant
concentrations, and 3) it will be the first to characterize the PK of β-nicotyrine and how it alters nicotine PK. In
so doing, this project could elucidate novel mechanisms mediating ENDS addiction and test the proposed β-
nicotyrine hypothesis.

Public health relevance
Project Narrative Electronic cigarettes heat and aerosolize liquids that contain nicotine and produce β-nicotyrine, which may be addictive and/or contribute to the addictiveness of electronic-cigarettes. The proposed project will seek to evaluate if β-nicotyrine has abuse potential and how alters the abuse liability of nicotine. The results will advance our knowledge on β-nicotyrine, which will inform regulatory policy at the FDA and help us understand how β-nicotyrine contributes to the development and maintenance of nicotine addiction.